Defining a Role for Atypical B Cells in RV-Induced Exacerbations of Allergic Asthma

PROJECT SUMMARY/ABSTRACT
Asthma is the second most common chronic respiratory disease worldwide. Nearly 8% of the entire US
population has asthma, a significant burden for public health. Most Americans have allergic asthma, which is
characterized by an underlying type-2 inflammatory response to allergens. All types of asthma are associated
with disease exacerbations; frequent exacerbations link to lung function decline in adulthood, suggesting a
chronic inflammatory process driven by these events. The most frequent trigger of asthma exacerbations is
respiratory viral infections, and up to 80% of viral exacerbations are caused by rhinoviruses (RV)—the primary
cause of the “common cold”. Work from the Woodfolk lab has demonstrated that increased numbers of RV-
specific T cells correlate with worse lung function in subjects with allergic asthma, even in the absence of
infection. Moreover, RV-specific T cell responses during infection were significantly amplified in subjects with
allergic asthma compared to healthy controls. Despite these striking findings relating to T cells, little is known
about the nature of RV-specific B cells in subjects with asthma or how B cells might contribute to persistent
inflammation in the disease. Our lab has previous investigated the phenotype and temporal dynamics of B cells
responding to RV infection in healthy subjects. We demonstrated that the majority of cross-strain B cell
memory to RV display an atypical B cell phenotype (T-bet+CXCR5-), are rapidly recruited to the upper airways
in response to infection, and rapidly produce IgG. These data led to my core hypothesis that atypical memory
B cells are magnified and dysregulated in subjects with allergic asthma due to the influence of the allergic
inflammatory milieu, and moreover, that the extent of this dysregulation is linked to disease severity. To
address my hypothesis, I propose to 1) define the pro-inflammatory nature of circulating RV-specific atypical B
cells in subjects with allergic asthma stratified by the severity of their disease, and 2) investigate how type-2
cytokines influence the expansion and pro-inflammatory functions of RV-responsive atypical B cells in vivo. I
will leverage a powerful experimental human RV infection model, novel analytical pipelines, and cutting-edge
integrative systems immunology techniques to address these aims. By using human models of investigation
and integration with clinical measures we are uniquely poised for translation into clinical practice. Moreover,
knowledge generated by these studies will inform the development of therapeutics designed to mitigate post-
viral sequalae in allergic asthma.
The highly collaborative training environment in the Woodfolk lab and the Division of Allergy is uniquely
suited for the pursuit of complex human immunology projects. I am privileged to access the advice and
mentorship of an inter-disciplinary team of translational and basic science investigators with expertise in
asthma pathophysiology. Completion of this project will further my training and career goals by exposing me to
cutting-edge high dimensional analysis and systems immunology techniques with wide applicability.

Public health relevance
PROJECT NARRATIVE Exacerbations of asthma caused by rhinovirus present an enormous health and economic burden to society; however, little is known about how the underlying immune events that contribute to chronic lung inflammation, and the role of B cells in particular is understudied. This project will leverage novel single-cell analytical methods and a human experimental infection model to resolve how pro-inflammatory functions of virus-specific B cells contribute to the severity of asthma. The knowledge gained will add a new dimension to understanding virus- induced asthma and identify new cellular and molecular targets for treatment.